High Plains Intermountain Center for Agricultural Health and Safety (HICAHS)(Porter)

SUMMARY
The success of the High Plains Intermountain Center for Agricultural Health and Safety (HICAHS) is grounded
in engaging and listening to stakeholders and responding to regional needs with sound and relevant programs
and partnerships. Building on a substantial record of accomplishments in research, intervention, education and
outreach, we propose an innovative transdisciplinary Center that leverages expertise and resources among
partners to promote a healthy agricultural and forestry/logging population in PHS Region VIII (Colorado,
Montana, North Dakota, South Dakota, Utah, and Wyoming) and beyond. Over the past 6 years we have fostered
a One Health approach with the rapidly expanding dairy industry in our region, responded to the disproportionate
COVID-19 impacts on agricultural workers, and strengthened partnerships in occupational safety with the logging
industry in Montana.
This proposal brings together an internationally recognized leadership team, outstanding new investigators, and
a well-developed regional partnership to address the new and unique needs of this region. Building on the
Regional Needs Assessment and following diversity, equity, and inclusion principles, we will continue to advance
health and safety in the region. The Mission of HICAHS is to improve the health and well-being of workers in
food, fiber, and timber production by engaging partners in transdisciplinary research, education, and prevention
programs across the region. The Center’s long-term goal is to reduce the risk of work-related injuries, fatalities,
and illnesses primarily in the agriculture and forestry subsectors in the region. We propose integrating new and
existing knowledge and using multiple routes of dissemination to translate research into improved agricultural
health and safety practices through our three Cores: 1. Evaluation & Planning Core; 2. Research Core including
our Pilot/Feasibility Program, two Basic/Etiological Research projects, one Intervention Research project, and
one Translation Research project; 3. Outreach Core including our Community-Initiated Grant Program. By
achieving our aims, we expect an effective Center infrastructure, cohesive and complementary research and
outreach efforts, and strengthened partnerships among researchers and practitioners working together to
support the agricultural and forestry workforce. Ultimately, we expect our work to contribute to the reduction of
risks of work-related injuries, fatalities, and illnesses and usher in our vision of a healthy and safe agriculture and
forestry workforce in the HICAHS region and beyond.

Public health relevance
RELEVANCE The proposed HICAHS Center includes cohesive and complementary research, intervention, outreach and translation efforts that address multiple NIOSH Strategic Objectives, NORA Strategic Goals, and CDC Healthy People 2030 Goals. The Center promotes health and reduces work hazards among high-risk industries within agriculture and forestry in Public Health Service Region VIII and beyond.